Role of Copper in LPS-mediated microglial activation

Abstract: Microglia are critical to maintaining the internal environment of the central nervous system (CNS). These specialized resident cells function to nourish and support neurons and to act as a first line of defense in response to neuronal injury. In response to a neuropathological state, quiescent microglia undergo a series of changes that result in the release of proinflammatory and cytotoxic mediators for the removal of the pathogen. Upon clearance of injured cells by phagocytosis and/or the removal of toxin and toxicants, microglia return to a resting state or undergo programmed cell death. Microglia, therefore, exhibit different phenotypes depending on their surrounding environment. Expression of the appropriate phenotype is critical to the successful removal of the pathogen and to limiting damage to surrounding neurons. Chronic microglial activation has been observed in a variety of neurodegenerative diseases but, to date, it is not clear whether microglial activation is due to a persistent neuronal degeneration that warrants their activated state, or to microglial dysfunction, including a failure to either upregulate or downregulate the release of cytotoxic mediators including nitric oxide (NO). NOis both a potent cytotoxic mediator and a key regulator of cellular signaling within microglia. Our hypothesis is that the phenotypic response of microglia to toxin exposure is dependent on the metabolic fate of NO. Redox active transition metals have been proposed as important factors in neurodegenerative diseases including Alzheimer's, Parkinson's and amiotropic lateral sclerosis. Levels of the transition metal copper are strictly regulated and deviations will alter NO signaling by changing the redox environment of the cell, particularly in reference to thiols. I propose to investigate the mechanisms by which copper alters copper- stimulated NO signaling and, thus, the phenotypic response of microglia. During the mentored phase of the award in the laboratory of Dr. Andrew Gow, I will investigate the effects of copper on phenotypic differentiation in immortalized BV-2 and in primary microglia cell cultures. In particular, I will examine how copper alters key- signaling molecules and the S-nitrosylation profile in response to an acute toxin challenge and how the presence of copper might interfere with the adoption of an adaptive inflammatory phenotype. The independent phase of the award will build upon the findings obtained during the mentored phase. During this phase I will investigate the effects of chronic copper overload on microglia phenotypic changes in specific anatomical brain structures in response to systemic LPS challenge in the tx j mouse. The effects of chronic copper overload will also be investigated with respect to whether the effects on microglia phenotype are permanent or can be reversed after excess copper has been removed.

Public health relevance
Project Narrative Microglia are the resident immune cells in the brain where they provide the first line of defense in response to neurological insults. In response to changes in the surrounding environment, the state of activation of microglia may change, that is, they may undergo phenotypic changes. These changes are usually accompanied by the release of pro- or anti-inflammatory products that will affect the outcome of the neurological insult. In this research project we propose to define the role that nitric oxide - one of the cytotoxic products of activated microglia - plays in the phenotypic differentiation of microglia and how copper (whose levels are elevated in a variety of brain pathologies), may interfere with the S-nitrosylation of protein synthesis in response to a toxin. Understanding the conditions that govern phenotypic changes in microglia may lead to the development of novel therapeutics in neurodegenerative diseases where microglia are in a chronic state of activation. __SpecificAimsTextDelimiter__ 10. Specific Aims: It is well documented that the neuropathology of a number of diseases is associated with activated microglia. A common environmental factor associated with these diseases is an elevated level of copper within the brain. However, at present, pathways of microglia activation are poorly understood; in addition, the role copper plays in neurodegenerative diseases needs to be defined. Pathogen-mediated activation of microglia is dependent upon the surrounding environment; in other words the presence of a low level of a toxicant (e.g. copper), that does not affect the normal functioning of the cell, may greatly alter the cell response elicited by a precipitating agent such a toxin (e.g. lipopolysaccharide, LPS). This proposal seeks to examine these interactions by utilizing a model system to determine the mechanisms by which toxin and toxicant interact. In particular, this model will characterize the role that nitric oxide plays in how microglia address the pathogenic event. Microglia are resident supportive cells of the central nervous system (CNS) where they survey their local microenvironment and are the first to respond to changes with a repertoire of supportive and protective activities. Failure to recognize a potentially dangerous signal, or to mount the appropriate response, may result in an adverse neurological outcome. Microglia are normally quiescent or down-regulated, but, in response to any disturbance to CNS homeostasis, they become activated and orchestrate a series of activities including the secretion of toxic molecules, the recruitment of additional immune cells and act as antigen-presenting cells (APC). The concept of phenotype, which has been traditionally associated with macrophages, has recently been extended to microglia [1], as it was recognized that microglia go through a series of transformations (i.e., phenotypic changes) in response to alterations in their immediate environment. It is well-established that LPS effectively activates microglia to an acute inflammatory phenotype [2] as it stimulates the release of pro- inflammatory cytokines, chemokines, prostaglandins and nitric oxide (NO). However, the mechanisms involved in controlling the development of different microglial phenotypes are unclear. Nitric oxide, is a multifunctional molecule that is physiologically necessary for a variety of functions within the brain including neuronal communication and regulation of vascular tone. NO is produced by activated microglia in response to pro-inflammatory cytokine stimulation and is unique in that it is both critical to the function of the microglia (e.g. pathogen clearance), but also regulates cellular function (e.g. expressional changes, regulation of respiration, and induction of apoptosis) [3]. NO provides a key point whereby the environment can interact to alter microglial responses as NO-mediated cellular regulation is critically dependent upon redox status. In this way exposure to redox active molecules, such as copper, could significantly alter microglial responses to stimulation. Copper, the third most common trace element in the human body, is required for the catalytic activity of numerous enzymes The importance of copper in neuropathology should not be underestimated as it has been implicated in a variety of diseases ranging from Alzheimer's to Wilson's. Studying the mechanisms that govern the phenotypic response of microglia to a pathogen may depend on what happens to NO once it has been released, and copper may be one condition that alters phenotypic differentiation. We hypothesize that the phenotypic response of microglia to toxin exposure is dependent upon the metabolic fate of NO. Nitric oxide is capable of producing cellular signaling through a number of mechanisms including S-nitrosylation of key proteins such as NF-kB and p21 ras. Therefore, we propose that the presence of Cu(I), by altering the metabolic fate of NO, and in particular by altering S-nitrosylation of target proteins, will alter the phenotypic response of microglia to a toxin, such as LPS. In order to investigate this hypothesis, the following specific aims will be investigated: Aim 1. To examine the mechanisms by which Cu(I) alters the phenotypic differentiation of BV-2 microglia in response to LPS exposure. Preliminary observations have shown that Cu(I) inhibits NO release in LPS-challenged BV-2 without affecting iNOS expression. In this aim we will examine the mechanism of this Cu(I)-mediated effect and weather an alternative inflammatory phenotype is induced. Aim 2. To examine the effects of Cu(I) upon phenotypic differentiation of primary microglial cells in response LPS exposure. The adoption of a cellular phenotype in response to insult relies on the degree of plasticity of the responding cells. In this aim we will examine whether the phenotypic plasticity of primary microglial cells is comparable to that of immortalized BV-2 microglia. Aim 3. To determine the effects of chronic copper overload on microglia phenotypic changes in specific brain structures (i.e., basal ganglia) in response to systemic LPS challenge. The role that NO plays in microglia phenotypic differentiation and how copper alters NO signaling in response to bacterial challenge will be studied with respect to activation of microglia in specific anatomical structures in the txj mouse (a model of copper overburden). In addition, the effects of chronic copper overload on microglia phenotype will be studied after excess copper has been removed from the txj mutant.